Ex vivo maintenance of endothelial cell barrier integrity via gap junction modification to prevent early ischemic injury in solid organ transplantation

Project Summary
Organ transplantation (Tx) is the mainstay therapy for patients with end-stage organ failure. Yet, barriers
exist that preclude long-term graft survival. It is well-established that early injury to the allograft, during the
donor organ preservation and reperfusion phases, set the organ up for late failure. Based on studies from
our laboratory, ischemia-reperfusion injury (IRI) and early alloimmunity, mediated by memory T cells, are
among the most prevalent and inevitable early injuries affecting endothelial cells (ECs) as the first point of
contact. Thus, our scientific premise revolves around the allograft's endothelium as central to these insults.
The endothelium contains an intact layer of aligned ECs that are joined by cell-to-cell junctions and enables
them to communicate and form a protective barrier. During IRI and early alloimmunity, the EC barrier is
disrupted, predisposing the ECs to inappropriate antigen presentation ultimately resulting in late graft failure.
Thus, the EC barrier is vital for graft protection. Endothelial cell-to-cell communication is dependent upon
gap junctions including connexin 43 (Cx43). Whether Cx43 gap junctions play a role in protecting the EC
barrier and dampening EC immunogenicity against early injuries allowing for a therapeutic target, forms the
central question of our proposal. Based on our preliminary data, we hypothesize that stabilizing and/or
overexpressing Cx43 gap junctions in ECs will mitigate early graft injury. To study this hypothesis, we
propose two Aims: Specific Aim 1 - Elucidate the role of Cx43 gap junction protein on EC
activation/immunogenicity during IRI in vitro. Specific Aim 2 - Demonstrate the preclinical ability to
downregulate the EC activation/immunogenicity in transplanted hearts in vivo by maintaining Cx43
protein levels via pre-treatment of donor hearts. Common to these aims, we will employ an in vitro model
of injury that simulates cold ischemia and warm reperfusion injury to study the role of Cx43 gap junctions on
EC health and immunogenicity. We will also employ clinically relevant in vivo brain-death mouse models of
IRI and alloimmune cardiac Tx and utilize a novel and unique donor organ pre-treatment strategy to deliver
Cx43 modulating agents. These innovative and high-risk high-reward studies will be the first to define the
specific and focused impact of Cx43 gap junction in ECs, associated with organ preservation and
reperfusion. Furthermore, it will provide a proof-of-concept to target the Cx43 gap junction in ECs prior to
transplantation using our unique pretreatment strategy which will set a stage for a paradigm shift in the
current standard of care during organ Tx.

Public health relevance
Project Narrative Transplantation is the only treatment for patients suffering from end-stage organ failure and early injuries in the donor organ are attributed to long-term failure. New therapeutic strategies are needed to mitigate early injuries and improve organ transplantation outcomes. The endothelium in the donor organ is central to early injuries and therefore, we seek to investigate the role of protecting the endothelial barrier in mitigating early insults.